FY25 FACILITIES TO E - 126663 B539 MISC SAFETY UPGRADES

The purpose of this project is to address a myriad of safety issues around B539. These are in areas that were not affected by the recent Phase 1 or Phase 2 Refurbishment efforts.